Measurement and Multimethod Validation of Alcohol Use Disorder Etiologic Mechanisms

PROJECT SUMMARY
Alcohol use disorder (AUD) is a significant public health problem, yet treatments demonstrate only modest
efficacy, likely due to the the profound phenotypic heterogeneity of AUD. In order to improve the efficacy of AUD
treatments, it is imperative to better characterize this heterogeneity which may, in turn, elucidate clearer
treatment targets for precision medicine approaches. This likely requires shifting conceptualizations of AUD away
from clinical description and towards etiologic mechanisms, an approach embodied by the goals of some modern
conceputalizations of AUD, such as the Addiction Research Domain Criteria (AARDoC) and Addictions
Neuroclinical Assessment (ANA). However, current research suggests that AARDoC and ANA suffer from
important shortcomings, including limited clinical efficiency, and may therefore benefit from further development,
refinement, and validation. To address these shortcomings, the proposed project aims to (a) empirically test the
models articulated by modern conceptual AUD etiological frameworks, including the ANA, and (b) derive a
mechanism-based computerized adaptive test (CAT) assessment of AUD developed using principles of objective
test construction and community-based participatory research strategies. First, a candidate set of self-report
items indexing 13 etiologic domains articulated by the Etiologic, Theory-Based, Ontogenetic Hierarchical (ETOH)
framework of AUD mechanisms, which serves as a recent extension of AARDoC/ANA, will be derived from the
literature and two rounds of cognitive interviews will be used to refine the item set among a diverse group of
participants (N = 50) with hazardous or harmful alcohol use. Next, items will be administered to a combined
community and clinical sample (N = 1,200) to empirically test the structure of items and determine the best-fitting
model. Item response theory will then be used to calibrate the items for the purpose of building a CAT for each
of the domains identified (e.g., reward, cognitive control, negative emotionality). Using the refined and calibrated
item set and domain-specific CATs, data will be collected from an additional independent sample of heavy
drinkers (N = 100). Ecological momentary assessment over 14 days and a follow-up assessment will also be
conducted with the goal of evaluating the psychometric properties of the CATs in ecologically valid contexts and
over time. Specifically, to determine if the domain-specific CATs demonstrate validity (e.g., convergent,
discriminant, predictive) and reliability (e.g., test-retest) across diverse patient populations and sex/gender
groups. All research aims will be conducted alongside and in consultation with individuals with lived experience
of AUD to ensure the measure is acceptable, feasible, and adequately contextualized. This project is consistent
with NIAAA's Strategic Plan, specifically Goal 1 (Identify mechanisms of alcohol-related pathology) and Goal 2
(Improve diagnosis and tracking of AUD). The resulting measure also has the potential to support progress
towards Goal 4 (Develop and improve treatments for AUD) by facilitating the assessment of mechanisms that
may serve as viable targets in AUD treatments, including behavioral and pharmacological interventions.

Public health relevance
PROJECT NARRATIVE To improve alcohol use disorder treatment, particularly through precision medicine approaches, it is imperative that alcohol use disorder etiologic mechanisms are identified and assessed in a way that is reliable and valid across diverse groups of individuals. The proposed study will use a multimethod approach to develop and validate a computerized adaptive test of alcohol use disorder etiologic mechanisms. Ultimately, the goal of this work is to establish an efficient and comprehensive assessment of mechanisms that can be used in service of determining the optimal treatment, whether behavioral, pharmacological, or both, for a given person with alcohol use disorder.